Human/Animal Exposure

HUMAN AND ANIMAL EXPOSURE (HUMANE) FACILITY CORE – ABSTRACT
The HUMan and ANimal Exposure (HUMANE) Facility Core provides CEED members with unique and powerful
tools to fulfill the Center’s vision of addressing the environmental health concerns of NJ residents by focusing
efforts on the environmental challenges of its most affected populations. HUMANE works with basic and clinical
researchers to design and implement experiments that assess how individual or complex real-world exposures
affect biological response indicators linked to adverse health outcomes in humans and animal models. HUMANE
utilizes cutting-edge exposure generation platforms coupled to real-time and time-integrated measurement of
legacy and emerging environmental/occupational toxicants in the Core’s human Controlled Exposure Facility
(CEF) and the Animal Exposure Facility (AEF). HUMANE also assists CEED investigators with inhalation
exposure studies aimed at examining the interactions between relevant toxicants and variables such as
temperature, humidity, physical activity, psychosocial stress, and pre-existing conditions or co-morbidities.
During the current grant cycle, the Core has strengthened its longstanding expertise and capabilities in
generating controlled gaseous and aerosol exposures by incorporating platforms capable of generating and
characterizing environmental nanoparticles that recapitulate those generated by multiple sources including
wildfires, incinerated micro-nanoplastics, e-cigarettes, and engineered nanomaterials. The capacity of HUMANE
to conduct both controlled animal and human exposure studies facilitates bidirectional translation of research
findings. By studying biological indicators and responses in humans and animals, insight is gained into
mechanisms of disease pathogenesis, which can be targeted for intervention strategies. The Core benefits from
robust interactions with the Translational Research Support Core (TRSC) and the Biological/Environmental
Indicators and Responses (BEIR) Facility Core, which facilitate productive interdisciplinary collaborations and
ensure high standards of QA/QC and safety in study protocols. The Core’s utilization is expected to increase
significantly during the next grant period due to planned investments in mechanical systems and equipment for
the CEF and AEF that simulate extreme weather scenarios. These new capabilities will allow CEED investigators
to study the interaction of environmental pollution with climate change-induced conditions that disproportionately
affect already overburdened populations and communities. The renovation of the CEF will also allow CEED
investigators to assess the efficacy of interventions to reduce the transmission of airborne infections under
controlled environmental conditions that recapitulate climate changes.